Administration Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE (AC)
The URI-led Sources, Transport, Exposure, and Effects of PFAS (STEEP) Superfund Research Program
(SRP) Center is focused on innovative research to determine: the ubiquity of emerging poly- and perfluorinated
alkyl substances (PFAS) in drinking water (Cape Cod study site); the suitability of current federal regulatory
standards; the significance of adverse health impacts, e.g., immune dysfunction and metabolic abnormalities
during early development and possibly beyond (Faroe Islands); the predictors of vulnerability to health impacts;
the development of novel detection tools (passive samplers) to test for the presence of precursors and
concentrations of PFAS in groundwater and private wells; the implications of the presence of PFAS with regard
to bioaccumulation in humans, the food web, and the environment; the engagement of affected communities
with the presence and dangers of PFAS; and the dissemination of findings through state, regional, national, and
international stakeholders.
The STEEP II Administrative Core (AC) will continue its successful operation of the STEEP SRP Center by
integrating advice from both the Internal Advisory Committee (IAC) and the External Advisory Committee (EAC)
through regular retreats and joint video calls with the STEEP team. With the STEEP Coordinator's oversight and
coordination skills, the AC will keep STEEP on target with respect to finances, reporting requirements,
supplemental funding, data management, mission, and aims. The AC will further foster the integration of cores
and projects by leading and organizing core and project specific cross-cutting meetings, workshops, retreats,
and seminars for the STEEP team.
As host institution, URI remains committed to the success of the STEEP Center and pledges $100k per
annum toward STEEP II’s operation, including the STEEP Coordinator’s compensation, in addition to teaching
relief and funding two additional minority graduate student assistantships. The AC research translation team will
continue to serve in its central and well-integrated role of connecting intra-STEEP researchers to promote regular
communication and collaboration by working toward goals in a coordinated and interdisciplinary manner that
extends to the participating institutions. Beyond sharing data with interested parties external to the SRP Center,
a main goal of the STEEP II AC is facilitating data and knowledge-sharing between and among projects and
cores. The AC will ensure the success of the STEEP II Center through the following Aims:
Specific Aim 1: Ensure the efficient integration of STEEP II's projects and centers
Specific Aim 2: Provide leadership for STEEP II's mission and goals
Specific Aim 3: Ensure that STEEP II provides relevant and timely research translation, technology
transfer, and tools for stakeholders and communities
Specific Aim 4: Identify and work with new stakeholders and collaborators

Public health relevance
PROJECT NARRATIVE – ADMINISTRATIVE CORE (AC) Since 2015, when the first STEEP Center proposal was submitted, the universe of poly- and perfluorinated alkyl substances (PFAS) has substantially expanded, many have been recognized as major pollutants threatening public health across the U.S, and new adverse health effects have emerged, thus provoking a need to reconsider current guidelines for maximum concentration levels or exposure limits. The continuation of the proposed STEEP II SRP Center will characterize PFAS exposures and health risks, and address the evolving needs of communities affected by PFAS-contaminated drinking water, whether past or present, or by other sources of PFAS exposure, including contamination of the food web (fish/shellfish), consumer products, air, soil, and dust. Maintaining and accelerating STEEP’s focus on innovation and collaboration remains the AC’s primary goal, and its team will build on the success already achieved by STEEP I in regard to the forefront of PFAS science, the inspiration and training of the next generation of PFAS scientists, and supporting equitable community engagement, comprehensive research translation, and inclusive outreach.